Single-cell transcriptomics of complex bacterial communities

Project Summary
Gene expression in bacteria is heterogeneous even within genetically identical cells due to the stochastic
activation of many gene regulatory programs. The resulting phenotypic diversity often plays an important
functional role for bacterial communities, for example, facilitating horizontal gene transfer. This fundamentally
single-cell behavior cannot be resolved with population level measurements and, so far, has been studied in
pure cultures of genetically tractable organisms using low-throughput reporter-based assays. However, the
majority of bacteria in nature reside in complex microbial communities spatially organized into biofilms and
composed of multiple interacting members. Within such communities, a multitude of behaviors emerge from the
dynamic interplay of noisy gene expression states and responses to the heterogeneous microenvironment.
Absence of approaches for measuring phenotypic states within complex polymicrobial communities
simultaneously at systems scale and with single-cell resolution results in a lack of mechanistic understanding of
bacterial ecology and is therefore a critical barrier for the fields of microbiology and microbiome studies. During
my postdoc, I developed a high-throughput bacterial single-cell transcriptomics technology, microSPLiT
(microbial Split-Pool Ligation Transcriptomics), that allows to measure gene expression states in tens of
thousands of individual cells using only common laboratory equipment. In my lab, I aim to further extend
microSPLiT for single-cell transcriptomics of biofilms, as well as of complex bacterial consortia. Specifically, in
my first project we will create a single-cell gene expression map of single- and dual-species biofilms of
Pseudomonas aeruginosa and Staphylococcus aureus by a combination of spatial single-cell RNA sequencing
and time-lapse imaging. We will characterize where and how the specialized phenotypic subpopulations emerge
at different stages of biofilm development and how they change in response to competing species. In the second
project, we will interrogate the functional role of the intermittent and heterogeneous activation of diverse
metabolic and stress response pathways which we have observed even in isogenic cells and in absence of
external cues. Specifically, we will test the hypothesis that heterogeneous sampling of such states may promote
inter-species interactions with bacterial partners evolved to coexist in the same environment. In this project, I
aim to uncover the phenotypic subpopulations arising in key species from human gut microbiota grown either
solo or in pair-wise combinations with other co-occurring species. With these data, we will use gene regulatory
network modeling to predict the higher-order interactions between gut microbiota species and engineer higher
complexity consortia with predictable behavioral traits. The results will pave the way toward building systems-
level understanding of the phenotypic structure and the emergent properties of a higher complexity natural
microbiota. Overall, the developed approaches will become widely applicable tools for microbiological research
and the acquired data will provide a foundation for high-resolution functional analyses of microbiota and biofilms.

Public health relevance
Project Narrative Even genetically identical bacteria may activate different subsets of genes leading to coexistence of diverse metabolic states and behaviors within a bacterial population. In this work, we will develop and apply high-throughput single-cell transcriptomics approaches to profile heterogeneous phenotypic states within complex bacterial communities such as spatially structured biofilms and reduced complexity microbiota. We will use the results to develop systems-level understanding of the fine-scale phenotypic structure and pave the way toward predicting the emergent properties of biofilms and natural microbiota.